Vanderbilt Training Program in Molecular and Genetic Epidemiology of Cancer

PROJECT SUMMARY
The rapid development and advancement of technologies and knowledge in molecular biology and genetics
have led to major breakthroughs in cancer etiology research. The field of cancer epidemiology is moving
rapidly toward a new era in which interdisciplinary and multidisciplinary collaborative research is the central
theme. This necessitates a growth of workforce of scientists working at the interfaces of epidemiology,
molecular biology, and genetics. The Vanderbilt Training Program in Molecular and Genetic Epidemiology of
Cancer (Vanderbilt-MAGEC), launched in 2012 with NCI R25 funding and currently supported by a T32 grant,
is designed to fill the gap with a goal of providing postdoctoral fellows from a variety of disciplines with the
methodological tools, practical laboratory and survey-research knowledge, and hands-on research and grant
writing experience necessary to launch an independent career in the molecular and genetic epidemiology of
cancer. The specific aims of the Vanderbilt MAGEC program are: 1) To recruit ethnically-diverse candidates
with strong backgrounds in epidemiology, genetics, and/or biology. 2) To deliver individualized didactic training
tailored to complement each trainee’s prior training background and launch them into their desired career
paths (molecular or genetic epidemiology of cancer). This training consists of courses, seminars, studios,
journal clubs, conferences and research grant preparation. 3) To establish a multi-disciplinary mentor team for
each trainee and integrate trainees into NCI-funded cancer epidemiology research projects. 4) To evaluate the
impact of the Vanderbilt MAGEC program by tracking short- and long-term outcomes. Expected short-term
outcomes for all trainees include publishing high-quality papers in peer-reviewed journals and submitting a
grant proposal to an internal or external funding agency based on the NIH format. Long-term outcomes include
cancer research career placements and NIH grant funding. The MAGEC program, built upon an outstanding
research and education training environment; a pool of 31 excellent, well-funded researchers and educators;
100 ongoing, cutting-edge research projects; exceptional data/biospecimen and population resources; and a
rich history of interdisciplinary training, has met remarkable success during the current grant cycle. During the
last 4 years and 9 months, 12 fellows received or are currently receiving MAGEC training; of these, 2
graduated trainees obtained faculty positions, and both received K12 fellowship awards, and one received two
additional career development awards. Another five graduated fellows are working in research-intensive
settings. Trainees contributed to 56 publications, 30 as first author. The program is mature and is in an
excellent position to continue growing. The renewal program will support 6 postdoctoral fellows. The expected
training duration for the MAGEC program is 3 years. Continued support of the program is essential for
sustaining its success and extending its impact on training a new generation of elite molecular and genetic
cancer epidemiologists and leaders in the new era of precision medicine and prevention.

Public health relevance
Narrative The Vanderbilt training program in Molecular and Genetic Epidemiology of Cancer is designed to build an elite class of epidemiologists to lead the new era of multidisciplinary collaborative research in cancer. The program, built upon an outstanding research and education training environment; excellent body of researchers and educators; multiple, ongoing, cutting-edge research projects; exceptional data/biospecimen and population resources; and the rich history of interdisciplinary training at Vanderbilt, delivers individualized didactic and research training to equip postdoctoral fellows from a variety of disciplines with the methodological tools, practical laboratory and survey-research knowledge, and hands-on research and grant writing experience necessary to launch independent careers in the molecular and genetic epidemiology of cancer.